The Center for the Global Demography of Aging

This core brings together researchers from across Harvard. While many established researchers in our themes have been successful in generating publications and grant support and in gaining policy influence, less established researches often need help to thrive in the field. This core will assist by harnessing senior researchers as theme leaders to mentor postdoctoral fellows and help junior faculty develop pilot projects.